Assessing the Interrelationship Between Adipose Tissue Thermogenesis and Fibrosis in the Metabolic Health of People Living with HIV

PROJECT SUMMARY/ABSTRACT
Insulin resistance is a driver of type 2 diabetes (T2D). Despite viral suppression, people living with HIV (PLWH)
have concerningly high rates of both insulin resistance and T2D. In determining what underlies this, we have
focused on the fact that whereas obesity is a common trait in humans, T2D risk is increased by “metabolically
unhealthy obesity” (MUO). Emerging observations highlight two factors promoting MUO in the general
population: 1) reduced mitochondrial content and fewer mitochondria-enriched “brown/beige” adipocytes in the
subcutaneous fat (SCAT) and 2) development of SCAT fibrosis. Interestingly, limiting brown/beige fat biogenesis
in mice promotes SCAT fibrosis and insulin resistance, whereas increasing it remarkably blocks fibrosis and
improves insulin sensitivity. With this in mind, we and others have observed that PLWH have dramatically
increased SCAT fibrosis, prompting us to wonder whether PLWH also have suppressed brown/beige fact activity,
and what factors dictate this. To this end, we recently identified a subset of adipogenic precursor cells (APCs)
expressing signature markers (Lin–: PDGFRa+: CD81+) that control a reciprocal balance between beige fat
biogenesis and SCAT fibrosis. Specifically, CD81+ APCs give rise to mitochondria-rich brown/beige adipocytes,
whereas CD81 deficiency leads to both SCAT fibrosis and insulin resistance. These data highlight the intriguing
possibility that CD81+ APCs in the SCAT may influence the development of MUO in PLWH. Beige/brown fat is
also a metabolic sink for branched-chain amino acids (BCAAs), the circulating levels of which are linked to human
insulin resistance. Activating brown/beige fat biogenesis either pharmacologically or by cold exposure clears
circulating BCAAs in humans; indeed, BCAA clearance is a noninvasive indicator of brown/beige fat activity.
However, BCAA catabolism has not been assessed in PLWH. We hypothesize that a reduced capacity of CD81+
APCs to maintain normal SCAT beige/brown function, reflected by both SCAT fibrosis and impaired BCAA
clearance, drives insulin resistance in PLWH, and that reversing this may improve metabolic health. Leveraging
an innovative cohort of PLWH and uninfected controls, including those with MUO, we propose to test this
hypothesis by A) examining the extent to which loss of CD81+ APC abundance, proliferative capacity, or
differentiation potential predicts SCAT fibrosis and insulin resistance in PLWH (Aim 1); and B) evaluataing BCAA
catabolism, alongside cutting-ege PET-CT quantification of brown/beige fat activity, as a determinant of glucose
homeostasis in PLWH (Aim 2). These studies will be coupled to aligned mechanistic studies in the HIV viral
accessory protein (Vpr) transgenic mouse model, which is interestingly prone to both insulin resistance and
impaired brown/beige fat thermogenic function. By validating a mechanistic index of SCAT health (CD81+ APCs,
fibrosis, BCAA clearance) that predicts MUO, we may reveal ways to prolong the metabolic healthspan of PLWH.

Public health relevance
PROJECT NARRATIVE Metabolically active fat rich in mitochondria (called “brown” or “beige”) maintains insulin sensitivity in healthy individuals, an ability that diminishes with obesity and advancing age in association with a process called fat fibrosis that is closely linked to insulin resistance and type 2 diabetes. Despite HIV medications that have sharply curbed the prevalence of AIDS, the growing population of people living with HIV (PLWH) have concerningly high rates of insulin resistance and diabetes and recent work, including from our group, shows that PLWH also have profound fat fibrosis. We have developed highly innovative tools to monitor brown/beige fat cells in both PLWH and a mouse model of HIV, and propose to use these tools to determine the extent to which a specific subset of fat cells marked by the protein CD81 dictate the propensity of PLWH to develop both fat fibrosis and insulin resistance, providing insight into to new interventional opportunities.